JAK2V617F, clonal hematopoiesis and atherosclerosis

Project Summary/Abstract
Conventional risk factors such as hypercholesterolemia, diabetes and hypertension are
incompletely predictive of cardiovascular disease (CAD), suggesting additional unidentified risk
factors. Recent studies have identified clonal hematopoiesis of indeterminate potential (CH) as a
new cardiovascular risk factor and a potential major driver of atherosclerosis in the elderly. CH is
caused by mutations that endow a proliferative advantage to hematopoietic stem cells, commonly
involving epigenetic modifiers (TET2, DNTM3a, ASXL1) or signaling pathways (JAK2).
Understanding the mechanisms underlying the association of CH with CAD is highly relevant in
precision medicine and has the potential to lead to novel targeted therapies for CAD. Acquired
activating mutations of JAK2 in hematopoietic tissues, with JAK2V617F (JAK2VF) as the most
common, drive development of myeloproliferative disorders and CH; amongst the different CH
genetic variants JAK2VF is most clearly associated with increased risk of CAD. Until recently the
causal relationship had not been directly assessed. We published a study recently using a mouse
model carrying the authentic human like Jak2VF mutation and demonstrated potent pro-
atherogenic effects of hematopoietic Jak2VF expression. In this proposal, we will follow the leads
and generate novel mouse models including hematopoietic lineage specific Jak2VF expression
and Jak2VF-driven CH to explore the mechanisms underlying Jak2VF-driven atherosclerosis. A
deeper understanding of these mechanisms may lead to development of new therapeutic
approaches to managing CH-associated CVD risks, as will be evaluated in this proposal.

Public health relevance
Project Narrative This project is aimed to explore the mechanisms underlying atherosclerosis progression driven by JAK2V617F, an acquired mutation commonly identified in blood cells that is associated with increased risk of atherothrombotic cardiovascular disease.